17th, 18th and 19th editions of the International Workshop on Pediatrics & HIV

The International Workshop on Pediatrics & HIV is organized on an annual basis prior to the biennially organized IAS or AIDS Conference. This workshop is the only meeting entirely devoted to research in prevention and treatment of HIV infections in infants, children, adolescents and pregnant and breastfeeding women, making it the primary forum for the world’s leading researchers. By bringing together experts from different disciplines with presentations in a variety of formats, the meeting offers a collaborative setting where the latest developments are presented, discussed, interrogated, and evaluated. The 17th Workshop is scheduled to be held in Kigali, Rwanda and virtually on 11-12 July 2025, prior to the 13th IAS Conference on HIV Science (IAS 2025). The program will include topics from among the following: Antiretroviral Treatment in Infants, Children, and Adolescents; Clinical Management of Infants, Children, and Pregnant/Breastfeeding Women; Coinfections/Complications in Infants, Children, Adolescents, and Pregnant/Breastfeeding Women with HIV; Clinical Issues in HIV Negative Infants Exposed to HIV; Prevention of Vertical HIV Transmission – Interventions and Implementation; HIV Prevention & Treatment in Pregnant and Breastfeeding Women; Clinical Management Issues Specific to Adolescents; HIV (and STI) Prevention in Adolescents; and Pediatric HIV Case Finding Including Early Infant Diagnosis. Given previous success with this format, we expect the 18th and 19th editions to follow this same pattern, including a similar program and schedule. The meeting format is also highly innovative. Moving from a more traditional format of plenaries and oral abstract sessions, the organizers have introduced unique approaches including structured debates, oral poster presentations, poster walks, clinical-case presentations, curated panel discussions, video presentations and a social program including a networking dinner where early career investigators meet with senior researchers. Attendance has increased substantially in the last several years with 292 delegates in 2024; highly favorable annual evaluations underscore the Workshop’s importance. The aims of the workshop are to 1) provide a platform for presentation and discussion of the latest developments in the field; 2) gather leading researchers involved in pediatric and perinatal HIV in a stimulating, interactive forum; and 3) promote the next generation of researchers. The objective of this proposal is to provide support for three annual workshops including participation of plenary speakers as well as members from the community of adolescents with HIV infection, and to increase the number of scholarships for early career investigators.

Public health relevance
The International Workshop on Pediatrics & HIV is the only meeting entirely devoted to research in prevention and treatment of HIV infections in infants, children, adolescents and pregnant and breastfeeding women, making it the primary forum for the world’s leading researchers. By bringing together experts from different disciplines with presentations in a variety of formats, the meeting offers a collaborative setting where the latest developments are presented and investigators are supported and encouraged to continue their scientific work in this field.